Personalized visualization tool to improve communication between clinicians, Latinos with ADRD, and their care partners

Project Summary
Clear Session, Inc is partnering with UTHealth Houston to develop an innovative digital
visualization solution to increase engagement among Latino ADRD, their caregivers and
healthcare providers.
Evidence reveals racial/ethnic disparities in the quality of patient-provider communication
among ADRD patients. Health providers are lacking in the ability to communicate in a clear and
culturally competent manner with Latino ADRD patients and their care-givers.
We will design a linguistically- and culturally-tailored digital visualization tool that
enhances healthcare conversations by breaking down the information in clear and
comprehensible ways to help the patients better understand what is being discussed and by
removing communication barriers around literacy, numeracy, and education. Patients and
caregivers will also remember what is discussed as all the visual activity that occurs on the
screen can be saved as an animation and shared with family members.
Culturally- and linguistically-tailored communication between patient navigators and patients has
the potential to have significant positive impact.

Public health relevance
Project Narrative Clear Session, Inc will develop an innovative digital visualization solution to increase engagement among Latino ADRD patients, their caregivers and healthcare providers. We have a collaboration with UTHealth Houston to provide the academic background to tool development